Clinical Trials Specialist in Developmental Therapeutics

Project Summary
The planned activities describe a set of efforts that will build upon my interest in developmental therapeutics
and childhood leukemias. I will lead a team of physicians, research nurses, clinical research coordinators in the
Pediatric Oncology and Developmental Therapeutics (DVL) Program at the HICCC and develop a portfolio of
clinical trials, which includes NCI-sponsored studies. My goal is to increase the number of accruals to the DVL
clinical trials, which is already excellent, by expanding with marketing efforts and also grow the portfolio of clinical
trials at HICCC. I will continue my involvement in the Children’s Oncology Group (COG) Myeloid Disease
Committee and Developmental Therapeutics Committee. I will carry on my efforts in my current PI or co-PI
positions for open trials, i.e. the COG AAML1921 and AAML18P1 studies. I will develop a new COG study to
evaluate a novel method of dose de-escalation of tyrosine kinase inhibitors before treatment-free remission in
children with CML working with a junior faculty. In addition, I hope to identify barriers to the accrual of minority
patients in pediatric developmental therapeutics studies and institute a plan to improve it.
I am devoted to mentoring and training young faculty who will develop next generation research in pediatric
oncology. I will continue my efforts to train residents and fellows interested in pediatric oncology. I will help junior
faculty to establish their roles at HICCC/CUIMC and also expand their academic opportunities in cooperative
groups and collaborations with outside investigators.

Public health relevance
Project Narrative My research is focused on developing new therapeutic agents and finding the best way of treating pediatric leukemias. I take on leadership roles to promote clinical trials. I am also devoted to mentoring and training the next generation of doctors, including fellows, residents and medical students.